IGF::OT::IGF: STANDARDIZED RECHARGEABLE ELECTRONIC NICOTINE DELIVERY SYSTEM

The Contractor shall verify the electrical safety of the Research ENDS. The Contractor shall amend the Drug Master File with information based upon the above-described efforts.